MHC Genetics Core

Abstract– Core C: MHC Genetic Typing Core
The objectives of the MHC Genetic Typing Core are to support the genetic characterization and breeding strategy
of the rhesus macaque SPF Colony, with a focus towards optimizing the colony for AIDS-related research. The
Core's three aims build upon the current strengths of the Core and incorporate genome-wide approaches
towards more rigorous genetic characterization of the colony.
Specific aim 1: MHC Class I alleles, important to AIDS investigators, will be genotyped using high resolution
sequencing in collaboration with Wisconsin NPRC Genomics Services. The genotypes on 175 animals
will be obtained each year.
Specific aim 2: GbS (170 animals per year), whole exome sequence (WES) (24 animals per year) and whole
genome sequencing (WGS) (9 animals per year) will be generated to provide a) a more robust AIMs set
defining Indian and Chinese ancestry information both genome-wide and at specific loci, b) parentage
information to verify pedigrees and investigate colony origins, c) genotypic information to allow for the
identification of animals carrying known and newly identified alleles relevant for AIDS research and
impacting infectious disease pathogenesis and vaccine-effectiveness, and d) genetic data to share with
the broader research community.
Specific aim 3: Genetic data from Aims 1 and 2 will be used to maximize genetic diversity of the colony, while
maintaining sufficient numbers of animals with specific MHC Class I alleles and ancestry for SIV/HIV
related studies. Core C will work with the SPF Oversight Committee and Core A to assemble breeding
groups across our single colony using parent animals from original Colonies 1 and 2 and newly acquired
animals.
Our characterization of the SNPRC U42-supported SPF Indian rhesus macaque colony will provide critical
genomics-based information to ensure the availability of these valuable animals for AIDS researchers for many
colony generations to come. Furthermore, our genomics-based data will also be important for the planned
expansion of the U42-supported colony.

Public health relevance
Narrative– Core C: MHC Genetic Typing Core This genomics-focused project will characterize the SNPRC SPF rhesus macaque colony to enable breeding strategies that consider genome-wide genetic diversity and fitness of colony members, while still providing rhesus macaques lacking specific MHC I alleles for AIDS researchers.